Mechanisms of Metabolic Adaptation: from Single Molecules to Systems Biology

Project Summary/Abstract
Cells have evolved to sense external and internal chemical cues to maintain cellular homeostasis and ensure
survival under challenging environmental conditions. In response to environmental stressors, such as the
scarcity of nutrients or xenobiotics, cells efficiently adjust their metabolism, a process that is critical for their
survival and adaptation. To rewire metabolism, cells have evolved sophisticated mechanisms that sense and
regulate pathways in response to stressors. In recent decades, significant advances have been made in
identifying metabolic pathways in cells responding to both internal and external chemical cues. Autophagy and
cytochrome P450 metabolisms are two pathways that are activated under conditions of nutrient and chemical
stress. A considerable challenge persists in understanding how these mechanisms respond during metabolic
adaptation. This knowledge gap not only hinders the understanding of how cells maintain response flexibility
across diverse conditions but also limits the ability to design targeted and effective treatments that depend on
metabolic adaptation. Thus, unraveling these complexities is crucial for developing more precise and impactful
strategies against a variety of chronic diseases. The PI has recently developed genomics and imaging
approaches that enable the quantitative interrogation of metabolic adaptation in human cell models, and with
these tools, proposes to address this knowledge gap. This approach pairs CRISPR-inspired genetic
perturbations and genome engineering techniques with state-of-the-art single-molecule microscopy and live-cell
imaging. For this proposal, the lab will synergize microscopy and genomics studies with mass spectrometry
proteomics, determining the assembly of metabolic complexes and post-translational modifications critical for
metabolism rewiring. This unique approach will allow systems biology study of metabolism – from single molecule
to cell-wide molecular changes. In this proposal, the lab will determine how autophagy and cytochrome P450
metabolism pathways respond to metabolic adaptation. For autophagy, preliminary data pinpoint WIPI-mediated
phospholipid sensing as a key regulatory factor in autophagy progression during nutrient stress. However, the
role played by the multiple WIPI isoforms and how they differently concur in autophagy progression remains
elusive. The lab will precisely define the molecular interplay between phospholipid signaling and WIPI isoforms
in the context of autophagy activation under the condition of nutrient stress. For the cytochrome P450 side of the
proposal, the lab will unravel the assembly and function of cytochrome P450 metabolic complexes upon
xenobiotic stress in the living cell: this is one of the oldest, yet still unresolved, questions in the field. Not only
results from this proposal will provide quantitative measurements on cytochrome P450s molecular assembly but
also set a path for discovering novel protein interactors. Together, this proposal will serve as a roadmap for
understanding metabolic adaptation in several chronic diseases.

Public health relevance
Project Narrative Unraveling the mechanisms of autophagy and cytochrome P450 metabolism, this proposal uniquely combines live-cell imaging, single-molecule fluorescence, and proteomics, to shed light on these critical pathways activated in response to environmental stress. The study aims to provide unprecedented insights into metabolic adaptation, paving the way for both fundamental understanding and potential translational applications. Ultimately, this research has the potential to significantly advance our knowledge of cellular responses to stress, impacting diverse fields from basic biology to therapeutic development.